GPU workstation for deep learning-based protein design and cryo-EM data processing

Abstract
We are requesting funds to purchase a GPU workstation that will be used for (1) deep learning
in the context of protein design and (2) for solving protein structures using cryo-EM data.
Currently there is a revolution going on protein modeling as deep learning methods have shown
impressive success in both protein structure prediction and protein design. We are leveraging
these new approaches in several ways that require access to GPU processers. First, we have
developed a new protein design pipeline that iterates between protein structure prediction with
AlphaFold and sequence optimization with a graph neural network to evolve sequences for a
specific function. Initial experimental validation of the pipeline is very encouraging, and we are
now eager to test it on a variety of protein design problems including the design of competitive
inhibitors, protein switches and biosensors. The pipeline requires large blocks of GPU time
(several days with multiple processors) to identify promising designs for experimental validation.
Second, we are training new neural networks for improved performance in protein design.
Access to GPUs is required for rapidly testing alternative network architectures and
hyperparameters. The last step of many protein design projects is validation of the design model
with a high-resolution structure. Some of our projects involve systems large enough to be
studied with cryo-EM and we are now in need of computational resources to structures from
cryo-EM data. Almost all modern cryo EM packages rely on GPUs for processing data.

Public health relevance
Project Narrative Deep-learning and cryo-EM are revolutionizing protein modeling and structural biology respectively. This supplement requests funds to purchase GPUs that will be used to for training neural networks, designing proteins with AI-based methods, and solving structures of designed proteins with cryo-EM.